INCIDENCE OF TARDIVE DYSKINESIA IN OLDER PATIENTS

Prospective study of 200 psychiatric patients over age 45 with selected psychiatric and neurologic assessments and clinical as well as instrumental evaluation of orofacial/limb motor function.